CD43 EPITOPES ON MURINE LYMPHOCYTES

Currently, my research involves a biomedical approach to defining the isoforms of the CD43 molecule. Using a chemiluminescent detection system, western blots of whole cell lysates has revealed the S11 mAb recognizes four species of molecules. In contrast, the S7 MAb detects only one. The further characterization of these species is the next step in my research which will include metabolic labelling and pulse chase experiments. We have begun our collaboration with Blair Audman at Tufts University. Unfortunately, what he thought was a CD43 "knockout" mouse was, in fact, only a partial knockout of the cytoplasmic portion of the molecule. He is continuing to work on a true knockout. KEY WORDS: Leukosialin, adhesion molecules, monoclonal antibodies